Anatomical connectivity and activity in primary visual cortex of mouse

Project Summary
Estimates of the total length of axonal "wiring" in the human brain are on the order of hundreds of thousands
of kilometers. Understanding the fundamental principles underlying the connectivity between cells is a daunt-
ing task, but it has become increasingly clear that there are canonical connectivity patterns across the layers
of the mammalian cortex. Many of these pairwise connectivity rules between cells have been discovered using
multi-patching in slices, but examining higher-order connectivity motifs (for example, triangular motifs) is difﬁcult
in the slice preparation. Furthermore, a central explanatory goal of neuroscience is to relate functional proper-
ties of neurons to the underlying connectivity between them. Achieving this goal requires overcoming signiﬁcant
technical challenges, but a few heroic studies have managed to identify such functional/structural principles such
as enhanced "like-to-like" connectivity in visual cortex cells that prefer similarly oriented stimuli. Over the past
ﬁve years, our team has participated in a "moon-shot" project as part of the IARPA and BRAIN Initiative-funded
MICrONS project to collect functional and synaptic-scale anatomical data from a millimeter cube of mouse visual
cortex. Functional in vivo calcium imaging of this volume was performed at Baylor College of Medicine in Hous-
ton, then the mouse was shipped to Seattle where the same volume was extracted, prepared, sliced at 40nm
thickness, and imaged on an array of advanced electron microscopes. Finally, the approximately two petabyte
image stack was ﬁnely-aligned and segmented by Sebastian Seung's group at Princeton. Achieving this ambi-
tious goal took almost the entire ﬁve years of the MICrONS program which ended in July 2021. This data set
has now beeen shared with the entire neuroscience community and has huge untapped potential for scientiﬁc
discovery. In Aim 1 we will use graph theoretical methods and focus our analysis to identify local higher-order
circuit motifs across layers and large-scale modules between excitatory neurons across cortical layers focusing
in mouse V1. We will test the hypothesis that groups of excitatory neurons form tightly-connected modules with
sparse, reciprocal connections to other modules. In Aim 2 we will focus on relating structure to function. At the
local circuit level we will characterize the relationships between stimulus selectivity and connectivity within and
across cortical layers in V1. We will test the hypothesis that connected groups of neurons (i.e. structural modules)
form computational modules to represent similar stimulus preferences (such as textures). For these analyses we
will leverage validated deep learning predictive models that provide a ﬂexible, systematic method to characterize
even non-classical, non-linear feature selectivities of neurons and ﬁnd the neuron's most-exciting inputs.

Public health relevance
Project Narrative The human brain contains hundreds of thousands of kilometers of "wiring" connecting neurons together; these connections enable information ﬂow in the brain and determine which neurons can communicate with each other. Understanding the principles governing the connectivity between cells is critical to understanding how the brain works and how communication between neurons can break down in different disease states. To learn these principles we will analyze a unique data set - years in the making - that contains all the connections between neurons in a millimeter cube of a mouse's brain, and information about how those neurons functioned when the animal was awake and watching a movie.